Deep cell history tracking: engineering cells that write their detailed life stories into their DNA to study DNA damage

Project Summary
DNA recording is a recently developed technology that allows cellular signaling events of interest to be followed
over time without removing cells from their physiological context. During a DNA recording experiment, genetically
engineered cells expressing the DNA recorder acquire mutations at a “recording locus” as the result of transient
cellular events, without perturbing their normal phenotype. At the end of the experiment, once their eventual
phenotype is known, cells can be collected and their histories determined by sequencing the recording locus.
The work proposed here will lead to a DNA recorder that is not limited, as current technology is, to recording one
or two cellular events per experiment, but can record dozens of events in parallel, allowing an unbiased
examination of cell history in any context compatible with genetically engineered cells. In this project, the new
DNA recorder will be used to study long-term effects for a cell of experiencing significant spontaneous DNA
damage. Although DNA damage is very well-studied, it has not previously been possible to follow the rare cells
that experience significant spontaneous damage, especially in an in vivo mammalian context. The new DNA
recorder will be developed in stages: First, intracellular recording machinery, based on a pre-existing recorder,
will be created for a small number of cellular events associated with the DNA damage response. Next, the fidelity
of this new recording machinery will be extensively validated in cultured cells and cancer xenografts. Finally, a
new recording architecture will be developed and validated, before being introduced into a transgenic mouse to
identify how spontaneous DNA damage affects cell fate determination during normal development.

Public health relevance
Project Narrative Every time cells divide, their DNA is damaged at a low level. This “endogenous” DNA damage is an important factor in normal and aberrant animal development, but because it happens at a low level over long time periods it hasn’t been possible to study in detail. I propose to develop a new tool with the resolving power to study endogenous DNA damage and other rare cellular processes over weeks to months in developing mammals.